Acquisition of Colaborative Robot System for Ultrasound Research

SUMMARY
Human fibroatheroma (FA) cap rupture leads to the formation of an occluding thrombus, myocardial infarction
(MI) and sudden death in more than half a million Americans every year. A major determinant of plaque rupture
risk is the atheroma cap thickness. However, there are several other factors that play an important role in the FA
cap rupture, including atheroma morphology, biological environment, tissue composition and mechanical
environment. Indeed, the underlying mechanisms for atheroma cap rupture are still insufficiently understood.
Vascular calcification has emerged in recent years among the factors that play an important role in the
stability of plaque rupture. We have demonstrated to date the existence of thousands of microcalcifications
(µCalcs) primarily in non-ruptured human atheroma caps using µCT imaging, and that they behave as an
intensifier of the background circumferential stress in the cap. In our currently funded NIH project
1R16GM145474-01 “Microcalcifications in Atherosclerotic Plaque”, the working hypothesis is that μCalcs in the
FA cap has a major effect on the FA cap rupture threshold. Unfortunately, µCT imaging cannot be used for in
vivo assessment of µCalcs in human subjects. Vascular and intravascular ultrasound, on the other hand, are
non-ionizing approaches routinely used for the imaging of atheroma.
Despite significant progress on intra/vascular imaging of atheroma using ultrasound, the presence of large
calcifications in the atheroma produce shadowing artifacts, lowering the image quality and the detection of
atheroma morphology, atheroma cap thickness and the presence of µCalcs. Also important, high-frequency
ultrasound imaging allow us to acquire high resolution images, but they are highly sensitive to micromotion of
the ultrasound probe, in particular for the imaging of speckles produced by small calcifications. To address these
shortcomings, we propose developing a 3D ultrasound tomography imaging approach for enhanced imaging of
human atheroma with calcifications. The ultrasound tomography approach is based on an automated scanning
robotic system comprising two collaborative robotic arms, one full-field 3D snapshot sensor and one
Programmable Logic Controller (PLC). The robotic system will allow us significantly reducing motion artifacts,
blurring, and shadowing due to calcifications in atheroma. This image quality improvement will be achieved by
implementing multi-angle compound ultrasound tomography, where the positioning of the emitter and receiver
imaging array probes will be controlled by the scanning robotic system. If the proposed automated scanning
approach is successful in providing improved images of atheroma with calcifications, we envision this approach
could be translated to in vivo imaging of atherosclerotic plaques, and detection of µCalcs in carotid vessels.

Public health relevance
PROJECT NARRATIVE Acquisition of an scanning robotic system will allow us improving the 3D imaging of fibroatheroma with calcifications and µCalcs performed under our research project “Microcalcifications in Atherosclerotic Plaque”. The automated ultrasound scanning system will reduce motion artifacts, blurring, and shadowing currently present in our images. If successful, this ultrasound scanning approach could be translated to in vivo imaging of atherosclerotic plaques, and detection of µCalcs in carotid vessels in future research.